Vital capacity & airflow measurement for voice evaluation: A vortex whistle system

PROJECT SUMMARY/ABSTRACT
Comprehensive voice evaluation requires assessment of the essential subsystems, including the respiratory
subsystem. However, surveys of assessment and treatment practices by speech-language pathologists (SLPs)
both in and outside of the United States indicate that respiratory and aerodynamic measures are rarely used in
the assessment of voice disorders, mainly due to lack of access to expensive equipment. The proposed series
of studies seeks to overcome this serious deficiency in the voice assessment practice of SLPs by combining
concepts and techniques from clinical voice science, acoustics, statistical methods, and aerodynamic
engineering. The result will provide accurate, low-cost measures of respiratory capacity and phonatory airflow
via the development and validation of a uniquely designed vortex whistle and accompanying signal analysis
software. A vortex whistle is a non-mechanical, non-electronic device that provides a whistle frequency that
varies proportional to the inlet airflow rate. When frequency is mapped to the inlet airflow rate, the area under
the frequency-flow curve obtained from the vortex whistle can be used as an estimate of volume. Rather than a
replacement for spirometry and other pneumotachometer-based aerodynamic instrumentation, our vortex
whistle design is optimized to obtain accurate measures of vital capacity (VC) and mean phonatory airflow (PA)
in sustained voicing that have important application to the assessment of respiratory and laryngeal function
essential for effective voice production. The vortex whistle can be manufactured for a tiny fraction of the cost of
pneumotachometer-based or other aerodynamic instrumentation. In addition, the platform-independent
analysis software can be used with low-cost computers and can be easily translated to mobile platforms.
The specific goals of this project are to: (1) develop a more complete understanding of the acoustic-
aerodynamic capabilities of the vortex whistle via computational aeroacoustic (CAA) modeling, (2) assess
hardware and software analysis modifications that can optimize the ability to provide accurate VC and PA
estimates from the vortex whistle via physical aeroacoustic (PAA) modeling that incorporates an actuated
syringe methodology for the production of highly controlled and repeatable airflows and volumes, (3) compare
and correlate measures of VC and PA obtained via the vortex whistle system (VWS) with high-quality
pneumotachometer-based aerodynamic instrumentation including the Koko SX 1000 spirometer and the
Phonatory Aerodynamic System (PAS), (4) correlate voicing onset frequency-flow characteristics with
underlying driving pressure (Psub), and (5) demonstrate the VWS as a noninferior alternative to “gold”
standard pneumotachometer-based instrumentation for measures of VC and PA in groups of nondysphonic
subjects across the lifespan and as a treatment outcome measure in a group of unilateral vocal fold paralysis
(UVFP) patients pre- and post-surgical medialization.

Public health relevance
PROJECT NARRATIVE The goal of this work is to promote more comprehensive voice assessment in routine clinical practice through the introduction of accurate, low-cost respiratory and aerodynamic measures via a uniquely designed vortex whistle and accompanying signal analysis software. The vortex whistle system is optimized for measures of vital capacity and mean phonatory airflow from sustained phonation that are essential to the clinical evaluation of voice. An optimized vortex whistle system will be evaluated as a noninferior alternative to “gold” standard clinical instrumentation that is often inaccessible due to several constraints such as high cost and limited portability.